Administrative Core

Administrative Core Project Summary
The Administrative Core of the UNC Alcohol Research Center entitled “MOLECULAR AND CIRCUIT
PATHOGENESIS OF ALCOHOL USE DISORDERS” is organized to foster and conduct interdisciplinary and
collaborative research on alcohol use disorders with a specific emphasis on molecular and circuit pathogenesis
underlying these disorders. In this renewal, we build upon the strengths of our Center by extending our
understanding of ethanol pathology mediated by dysregulation of neural circuits in the brain that mediate ethanol
addiction pathology through multiple diverse signaling pathways. The specific aims of the Administrative Core
are to provide scientific inspiration and administrative leadership for the Alcohol Research Center, monitor and
enhance interaction among the research components, optimize synergy and sharing of resources and services,
and organize seminars and workshops to stimulate exchange of scientific information among the Center faculty
and staff. Further, we work to stimulate new alcohol research programs at UNC and to disseminate new research
knowledge to health professionals, academics, college students, families and youth in NC. The Administrative
Core is involved in community outreach activities designed to improve awareness, prevention, and treatment of
alcohol use disorders. In addition, the Administrative Core oversees all budgetary issues, appropriate allocation
of funds as well as preparation of progress reports and the renewal of the ARC. In summary, the Administrative
Core is designed to maximize research rigor, significance, innovation, collaboration and productivity to advance
the research aims and to use scientific knowledge to improve health by educating health professionals, parents,
college students and youth.